Promoting Viral Suppression through the CHAMPS+ Intervention in the Deep South

Despite efforts to achieve UNAIDS 95-95-95 targets, marked deficits remain in HIV testing, antiretroviral
therapy (ART) adherence, and viral suppression (VS) among a growing number of persons with HIV (PWH).
Gaps in HIV treatment success are particularly pronounced in the United States (US) Deep South. These
suboptimal HIV health outcomes occur at a time when clinicians have limited time and the US healthcare
system remains fragmented, further exacerbating the challenges inherent in the lives of underserved,
marginalized groups, such as PWH. In this way, the development and evaluation of interventions using a
resource-savvy cadre of community health workers (CHW) holds promise for addressing these challenges.
Yet, gaps exist in the CHW literature, and research is needed to bring CHW interventions to scale to
ameliorate the large gaps in the US HIV Care Continuum, particularly in Ending the HIV Epidemic (EHE)
priority locations. In response, our highly experienced study team has developed and tested the Community
Health Workers And MHealth to ImProve Viral Suppression (CHAMPS) intervention which leverages mobile
health (mHealth) technology to create a multi-component intervention that targets multiple levels (individual,
social and sexual networks, and community) to improve ART adherence and VS. We propose to build on our
strong preliminary data of extant intervention work in PWH and directly respond to RFA-MD-23-007 by
leveraging our CHAMPS intervention which will be delivered by personnel from four HIV care settings in the
Deep South. The CHAMPS+ intervention is delivered via an mHealth platform to support PWH to self-manage
their ART regimens and adds to the extant CHAMPS intervention by adding a CHW-delivered supportive risk
reduction counseling (sexual behavior and substance use) during periods of non-suppression to prevent HIV
transmission. This proposed study also builds upon our mChoice (U01PS005229) and WiseApp
(R01HS025071) studies to improve ART adherence and VS in the Deep South. The proposed study design
has a three-fold purpose of: 1) engaging the target population in the development of culturally relevant
recruitment materials and retention strategies for the proposed study, 2) assessing the clinical effectiveness
and sustainability of the intervention in Deep South settings, and 3) evaluating regionalized implementation
factors guided by the Reach, Effectiveness, Adoption, Implementation, and Maintenance framework.
Ultimately, this study will test CHAMPS+ to promote ART adherence and suppressed viral load for PWH in in
Alabama, Louisiana (Orleans Parish), and Mississippi, US EHE prioritized jurisdictions. Importantly, our multi-
component intervention targets multiple levels to address HIV risk behaviors during periods of non-
suppression--an innovative and impactful component likely to be of great public health import.

Public health relevance
PROJECT NARRATIVE To achieve the Ending the HIV Epidemic: A Plan for America, better strategies are needed to promote antiretroviral (ART) adherence and viral suppression in persons living with HIV (PWH) from health disparity populations to engage them in HIV care and to reduce HIV risk behaviors during periods of non- suppression. In response, our study team has developed and demonstrated evidence for components of the CHAMPS+ intervention which will promote ART adherence and suppressed viral load for PWH who live in the Deep South, a geographic area of the US with high rates of new HIV infections and PWH who are virally unsuppressed.